Elucidating the mechanism behind oscillation between glycolysis and gluconeogenesis

Project Summary
Metabolism is a dynamic network of biochemical reactions capable of adapting to changing environments. In
changing glucose availability, glycolysis and gluconeogenesis support systemic glucose homeostasis. In the
parent award, we investigate the regulation and coordination of glycolysis and gluconeogenesis in mammalian
cells under dynamic nutrient environments. The goal of this supplement application is to acquire funding to
support one talented and motivated undergraduate student researcher for 10 weeks in the summer of 2023. She
will measure the rates of glycolysis and gluconeogenesis in mammalian cells under dynamic nutrient
environments by employing biochemical assays and mass spectrometry. She will be mentored by the PI and
one PhD student who will train her to perform cell culture experiments, metabolic measurements, and analyze
results. She will join the Bruins-In-Genomics (BIG) Summer Program on UCLA campus to broaden her scientific
horizons and develop professional skills. She will share her research outcomes with the PI’s research group and
other researchers on campus by presenting her project at the 2023 BIG Research Symposium. These activities
will further the undergraduate student researcher’s passion for biomedical science and act as a steppingstone
for her to become a future STEM leader.

Public health relevance
Project Narrative The parent grant supports investigations into the mechanisms behind the regulation and coordination of glycolysis and gluconeogenesis that support systemic glucose homeostasis in humans. The goal of this supplement application is to support a talented and motivated undergraduate student researcher as they develop scientific and professional skills. The undergraduate student researcher will measure cellular metabolic phenotypes and identify key metabolic regulation under dynamic nutrient environments.